Real-Time Monitoring and Automated Electrolyte Repletion Using Ion-Selective, Sensor-Integrated Central Venous Catheters

Project Summary: This study evaluates the performance limitations of a new ion sensor-integrated
central venous catheter (CVC) and an autonomous system designed for real-time correction of
electrolyte imbalances. In vitro and in vivo tests will measure the catheter’s accuracy, sensitivity,
stability, and the system’s ability to autonomously correct electrolyte imbalances with clinician
validation. The group aims to replace traditional basic metabolic panels in patients with an existing
CVC, revolutionizing hospital care by enabling early detection and treatment of metabolic
imbalances through automated systems while reducing the need for frequent blood draws and the
associated risk of hospital-acquired anemia.
Minimizing excessive blood drawn from critically ill patients is a major technical challenge in
intensive care units. To replace current blood draw practices, real-time non-phlebotomous
monitoring of blood electrolytes via an ion sensor-integrated CVC is proposed. This sensor
technology provides real-time, continuous monitoring in noninvasive and invasive settings. For
instance, intra-arterial blood glucose sensors have shown feasibility in improving diabetes
management accuracy. The capability of in vivo ion sensing depends on maintaining the sensor
surface’s integrity in blood environments while ensuring constant accuracy, sensitivity, and
specificity. The research proposes using a thin-film ion sensor with a protective membrane,
established under 1 mm thick film structures that seamlessly adhere to catheter surfaces. This
membrane will selectively penetrate target ions in the bloodstream and be made of biocompatible
materials, potentially including antithrombotic agents.
The study also introduces an automated electrolyte repletion system. Timely decision-making for
electrolyte or fluid infusions via PIVs or CVCs is challenging due to delays in lab results.
Continuous monitoring through a sensor-integrated catheter, combined with an infusion pumping
system with repletion protocols, could significantly aid ICU practitioners in addressing acute
physiological abnormalities. The system detects electrolyte imbalances using continuous catheter
data, validated programmatically for each analyte. It alerts when electrolyte levels reach hypo- or
hyper-status thresholds, enabling prompt implementation of repletion protocols. The proposed
system will adapt to current clinical repletion protocols, controlling infusion quantity, time, and
frequency. An integrated circuit board and application will analyze and determine the appropriate
protocol, enhancing ICU operations by efficiently addressing acute physiological abnormalities.
This approach promises to improve patient outcomes and streamline intensive care unit workflows.

Public health relevance
Project Narrative This study evaluates the performance identification of an in vivo ion sensor-integrated central venous catheter (CVC) and an autonomous electrolyte repletion system designed for real-time correction of electrolyte imbalances. In vitro and in vivo tests will measure the catheter’s accuracy, sensitivity, stability, and the system’s ability to autonomously correct electrolyte imbalances with clinician validation. This research aims to revolutionize hospital care by enabling early detection and treatment of metabolic imbalances through automated systems, thereby reducing the need for frequent blood draws and the associated risk of hospital-acquired anemia.